Bioanalytical Core

Abstract
The Bioanalytical Core is a continuation of the shared resources offered in Phase-2 COBRE on Dietary
Supplements and Inflammation (CDSI). The purpose of this Core is to assist and provide Pilot Project Faculty
and other researchers associated or otherwise with the CDSI with cutting-edge and cost-effective methods of
epigenetic and microbiome analysis that would lead to innovative and high-quality research. This Core
specializes in designing and performing innovative –omics (scRNASeq and ATACSeq) research. Services
provided by the Core in this area will include 1) Use of microarray-based approaches and bioinformatics tools
for analysis of microRNA, mRNA and lncRNA expression data as well as performing pathway analysis 2)
Performance of next generation sequencing-based assays such as ChIPSeq, MeDIPSeq, and RNASeq as well
as 16S rRNA and shotgun sequencing to determine the effects of natural products on the genome, epigenome
and microbiome, followed by data validation. 3) Screening and identification of natural product library for anti-
inflammatory properties as well as analysis of receptor-ligand interactions. Thus, this Core will provide COBRE
investigators with in-depth and complex analyses using specialized bioinformatics tools and statistical
approaches to address the mechanistic effects of natural products on inflammation. With the advent of –omics
technology that has resulted in the acquisition of big data, specialized technology and expertise are required for
analyses that are usually not found in individual laboratories. The Core will also provide services in structural
determination and binding analysis of natural compounds of interest to the CDSI and in understanding how
botanicals promote the genomic, epigenomic, transcriptomic and microbiome regulation of inflammation. The
Core will use an array of in silico analysis tools to determine natural compound structure and binding properties,
which will provide insights into not only the physical properties of these compounds but also significant
information pertaining to their functions as they bind and interact with various receptors. Results from these
studies will be validated with biochemical assays meant to determine how these compounds can modulate the
immune response. This Core is highly innovative and provides analytical tools that would lead to the identification
of novel modes of action of botanicals and targets of inflammation. This would aid CDSI to develop new
opportunities to pursue and advance inflammation research thereby promoting sustainability, a key component
of COBRE Phase-3. In summary, this Core will serve as a state-of-the-art hub for the pursuit of cutting-edge
research that should shed light on mechanisms of inflammation, including the identification of biomarkers for
diagnosis and prognosis as well as new drug discovery against inflammatory diseases.